The impact of aging on the functional and anatomical coupling between brainstem noradrenergic neurons and upper airway muscles

Project Summary
Obstructive sleep apnea (OSA) is a growing sleep-related breathing disorder with the prevalence rate of
10-15% in the middle-age adults and of 32%-62% in elderly. OSA patients undergo recurrent upper airway
collapse due to suppression of activity of upper airway dilator muscles during sleep, which causes repeated
hypoxia, frequent stressful arousals and sleep deprivation. OSA has a major health impact due to its
association with cardiovascular, metabolic and neurocognitive morbidities, including a risk factor for developing
Alzheimer’s disease and increased mortality in older adults.
Brainstem noradrenergic (NA) system plays an important role in maintaining the tonus of upper airway
(UA) muscles to keep airway open during wakefulness. Therefore, the decrease of NA release during sleep
largely contributes to a loss of the UA muscle tone at night, which is a major neurological cause of OSA.
Studies suggest that aging has a detrimental effect on the NA system. However, there is little information
regarding age-related changes in the control of UA muscles by brainstem NA neurons, which may be a basis
of the increased prevalence of OSA in older population.
In the proposed project, we will use a novel molecular-genetic approach that will allow a cell-type-specific
activation of NA neurons in the brainstem A1/C1, A5, A7 and SubCorelueus (SubC) nuclei while recording
activity of the genioglossus (GG), a major UA dilator muscle, during natural sleep and wakefulness in young (3-
4 months) and old (16-20 months) behaving DBH-Cre mice. We will determine the age-related changes in 1)
the ability of A1/C1, A5, A7 and SubC neurons to activate the GG muscle; 2) the contribution of A1/C1, A5, A7
and SubC neurons to depression of the GG muscle activity during NREM sleep and REM sleep; 3) the
number of NA neurons in these and other brainstem NA nuclei; and 4) the density of axons and their terminals
that originate from A1/C1, A5, A7 and SubC neurons and project to hypoglossal and other UA motoneurons.
The proposed work will reveal neurological bases of the reduction in effectiveness of UA muscles to
maintain UA open during sleep in older individuals. The results of this study will fill a major gap in our
understanding of underlying mechanisms of OSA pathogenesis in elderly and lay the groundwork for
translational research of OSA pathology in aging to develop preventive and/or therapeutic strategies for clinical
management of OSA in older patients.

Public health relevance
Obstructive sleep apnea (OSA) is a major public health problem, which is more prevalent in older individuals. The sleep-related decrease of the tonus of upper airway muscles, which keeps airway open in wakefulness, is a key neurological cause of the airway occlusion in most OSA patients. Since noradrenergic neurons significantly contribute to the maintenance of upper airway muscle tone, we will determine whether the functioning of these noradrenergic neurons is impaired with age; this information will be helpful for developing proper therapeutic strategies for the clinical management of OSA in older patients.